Evaluating kratom using a human drug development methodology

Project Summary
This R01 study will evaluate the safety, tolerability, and human abuse potential (HAP) of a well-characterized
whole leaf formulation of Mitragyna speciosa (“kratom”) in healthy adults. Kratom is a botanical indigenous to
Asia and predominantly legal in the US. This proposed study is essential as commercial kratom use grows and
as there are increasing indicators of the therapeutic potential for some kratom alkaloids. To date, there are no
published clinical data on the safety and HAP of kratom which could be used to inform our understanding of
relative risk or drug development pathways. Kratom leaves have over 40 bioactive alkaloids with opioidergic,
adrenergic, and serotonergic activity, which results in analgesic and stimulatory effects. Our prior research with
experienced kratom users found euphoria, analgesia, and increased energy/alertness following kratom use
along with additional HAP indictors of drug “liking” and “wanting.” Self-report suggests that whole leaf kratom
doses between 0.5-10g produce acute effects that are well tolerated among chronic consumers; this has not
been demonstrated in controlled clinical studies using healthy adults and a standardized formulation. Likewise,
the HAP of a standardized kratom product has not been determined, nor has there been a comprehensive
characterization of kratom’s pharmacokinetics (PK) and pharmacodynamics (PD). This R01 will fill critical
public health and scientific gaps through two projects: Project 1 will be a triple-blind, randomized, between-
subject single ascending dose evaluation of kratom to determine the safety/tolerability of a well-characterized
whole leaf kratom product. Eighty-eight (44 men/44 women) healthy adults across 11 cohorts will be
randomized to receive an active kratom dose between 0.5g to 10g. A-priori go/no-go criteria will determine
dose escalation; a low and high well tolerated dose will be selected, with contingency plans for dose selection
in place. Project 2 will be a triple-blind, placebo-controlled, within-subject evaluation of the low and high dose
of kratom (determined by Project 1) relative to a prototypic opioid and stimulant. Outcomes will be a HAP and
PK/PD characterization. Forty healthy adults (20 men/20 women) will complete 5 randomized outpatient
sessions, where they will orally ingest capsules of either: placebo, active kratom low dose, active kratom high
dose, oxycodone (10mg; opioid comparator), or methylphenidate (20mg; stimulant comparator). Outcomes will
include HAP, PD (physiological and subjective drug effect ratings, cognitive assessments), and PK. This R01
will be conducted by an interdisciplinary team with extensive substantive knowledge on kratom, and the
methodological skills needed for achieving all aims. This would be the first NIH-funded study to examine the
safety, tolerability, and HAP of kratom in humans and the first large-scale study to sensitively characterize
kratom PK/PD. Findings have immediate public health value as they articulate an empirically derived safe dose
and provide a relative risk profile of kratom’s HAP that we currently lack. They will also serve as a foundation
for future studies investigating therapeutic potential of isolated kratom alkaloids, beginning with mitragynine.

Public health relevance
Project Narrative Although there is increasingly widespread use of whole leaf kratom in the United States and globally, and although some individual kratom alkaloids show promise for therapeutic development, we lack fundamental clinical data on kratom’s safety, human abuse potential (HAP), pharmacokinetics (PK), and pharmacodynamics (PD). Findings from this R01 study will improve our clinical understanding of kratom’s safety among healthy adults and will determine ecological valid, well-tolerated low and high kratom doses that can be used to evaluate the HAP of kratom relative to comparators of oxycodone, methylphenidate, and placebo while permitting sensitive characterization PK/PD. Collectively, study findings will constitute a significant scientific stride toward bettering understanding kratom’s effects in humans, and will have immediate public health and policy relevance.